Overcoming the Barriers to Effective Transcranial Temporal Interference Stimulation in Humans

Project Summary/Abstract
One in three patients across neurological and psychiatric disorders are treatment resistant. Neuromodulation could
provide these patients with treatment options, but current invasive approaches carry significant risk, while noninvasive
approaches have low spatial resolution and cannot stimulate deep brain areas. Transcranial temporal interference
stimulation (TIS) is emerging as a novel tool that combines noninvasiveness with favorable focus, high focusing flexibility,
and the possibility to stimulate at depth. Successful applications to deep brain targets as well as flexible focusing have
been demonstrated in mice. This proposal takes the critical set of next steps so that TIS can be effectively applied to the
human brain.
In Aim 1, we will realize the key strength of TIS, applying it to deep brain nuclei of non-human primates. In a controlled
experiment, we will determine the intensity threshold that produces substantial effects on visual choice behavior, and
validate the safety of the stimulation. In Aim 2, we will apply TIS to the motor cortex of humans and use an established
method to elicit and measure motor evoked potentials in relation to the phase of the TIS waveform. Using this metric, we
will i) validate that effects of TIS are due to the beat pattern and not the carrier, ii) evaluate the effect of the TIS carrier
frequency, and iii) devise protocols for transient and sustained neuromodulation.
Together, our work provides protocols for effective and safe TIS modulation of the human brain. This development has
the potential to provide noninvasive and spatially specific treatment options to the large number of patients with brain
disorders that are resistant to, our counter-indicated for, existing forms of treatments.

Public health relevance
Narrative We will maximize the effectiveness of temporal interference stimulation using computational models and experimental applications in non-human primates and humans. The work will provide definitive confirmation of noninvasive and focal stimulation in humans, and of specific deep brain targets in monkeys, and thus has the potential to transform the way we diagnose and treat patients with brain disorders.